11th International Conference on Cryptococcus and Cryptococcosis (ICCC)

ABSTRACT
This proposal requests partial support for the 11th International Conference on Cryptococcus and
Cryptococcosis (ICCC) to be held in Kampala, Uganda, January 10-14, 2022. Cryptococcosis accounts for
15% of AIDS-related deaths globally. Cryptococcal meningitis remains the most common neuroinfection
among all adults in Sub-Saharan Africa and continues to be a major threat to a growing number of non-HIV
immunocompromised persons.
The broad and long-term goal of this ICCC is to bring together the world's leading researchers in this
expanding field to foster cross-disciplinary discussions, research, and clinical collaborations to enhance our
understanding of the mechanisms of Cryptococcus pathogenicity and best management of cryptococcosis.
The specific aims of this meeting will be to convene leading experts whose expertise covers critical
areas within this field, as well as early career and junior investigators, students, and postdocs. We
anticipate hosting 300 participants. The program will be structured into 17 sessions covering the diverse
properties and characteristics of the pathogen as well as host susceptibility and immunity, emphasizing
what makes a normal host suddenly susceptible to this disease. Importantly, the conference will provide
ample coverage of current and novel antifungals – ranging from pre-clinical development programs through
ongoing/future clinical trials. Abstracts from junior investigators, graduate students, and postdoctoral fellows
will be included among those selected for oral presentation. The conference will host two poster sessions
which will permit all participants to actively contribute to these topics. Of the 17 session blocks, 12 blocks
will be concurrent sessions to allow for smaller working groups to meet and more students / trainees to
present their abstracts. The R13 resources will go towards supporting travel grant participation by graduate
students and specifically under-represented minority scholars from US and Africa who present abstracts.
We will seek parity with respect to women and minorities in the selection of speakers and organizing
committee, starting with 2 of the 3 ICCC co-chairs being a woman or a minority. We will target at least
~40% of plenary speakers to be women and ~10% under-represented minorities. Childcare will be provided.
The 11th ICCC is significant because focuses on an important infectious disease afflicting both
immunocompromised and immunocompetent people. This is the only such conference that brings together
basic scientists and clinical investigators who investigate cryptococcosis. This is the first time the
conference will be held in Africa with objectives: 1) to build new US-African translational research
collaborations; 2) to define the important clinical, translational, and basic science research agenda to forge
new avenues for novel prevention and treatment strategies.

Public health relevance
NARRATIVE First considered a rare fungus in clinical settings, Cryptococcus neoformans emerged to become one of the world's most problematic opportunistic killers affecting those with weaken immune systems. As a consequence of the burden of cryptococcal meningitis associated to AIDS pandemic, the medical mycology community stepped up to face this challenge, brought in a number of new investigators and explored different angles of the fungus and disease it causes. One consequence was the organization of the International Conference on Cryptococcus and Cryptococcosis (hereafter ICCC), held approximately every three years since 1989. This proposal seeks funding for conference support for the travel of students and post-doctoral fellows presenting research abstracts at the 11th ICCC meeting in Kampala, Uganda in January 10-14, 2022.